Elucidating the mechanisms of Glis3-regulated development in the pancreas and kidney

Project Summary
Embryonic development is orchestrated through complex networks of genes that specify cell fates and choreograph the
migration and reorganization of cells into tissues. Mutations within developmental genes can both give rise to birth defects
and increase susceptibility to diseases later in life. The transcription factor, Gli-similar 3 (Glis3) has been found to be
important during embryological development and mutations within the GLIS3 locus have been implicated in the development
of several diseases including diabetes, Alzheimer’s disease, and cancer. Currently, little is known about the specific roles
Glis3 plays during development or how divergence from its normal function promotes disease at the molecular level.
In this proposal, experiments are described intended to characterize pancreatic and renal development in the glis3EX4del/EX4del
mutant zebrafish line that lacks functional glis3 expression. In Specific Aim 1, we will characterize pancreatic development
in glis3 knockout fish to determine what role glis3 plays in directing development of the pancreatic ducts and the specification
of secondary islets that emerge from the ductal epithelium. The experiments described in Specific Aim 2 are designed to
examine the mechanisms by which loss of glis3 expression results in cystic kidneys. Particular emphasis will be placed on
characterizing the association between glis3 and the mechano-sensory organelle known as the primary cilium. Finally, in
Specific Aim 3, plans are described to gain a better understanding of the specific cell types that express glis3 during
development and how loss of glis3 expression alters gene expression in the developing zebrafish by conducting scRNA-
seq analysis.
The research described in this proposal will be conducted at a regional comprehensive university that serves a
predominately rural, economically underdeveloped community for whom access to scientific research is traditionally
restricted. The research will be completed with extensive support from undergraduate researchers who will gain the
opportunity to co-author manuscripts and present findings at local, state, and national meetings.
Broadly, the completion of the studies outlined in this proposal will increase our understanding of how Glis3 specifies cell
fates during development and may help shed light on how Glis3 mutations lead to diseases in humans such as diabetes
mellitus and polycystic kidney disease. Furthermore, a greater understanding of the mechanisms that regulate pancreatic
and renal development is likely to be achieved including a more thorough knowledge of the transcription factor networks
that direct cell fates and tissue organization. Ultimately, completion of the research described may lead to the establishment
of a complementary zebrafish model for the study of human disease.

Public health relevance
Project Narrative GLIS3 mutations in humans are associated with a number of pathologies including polycystic kidney disease, congenital hypothyroidism, and diabetes mellitus. In this project, a zebrafish mutant deficient in glis3 is used as a model organism to gain a better understanding of pancreatic and renal development and function. Given the similarities between zebrafish and human development, the results of this study may eventually lead to the facilitation of novel therapies to treat diabetes and polycystic kidney disease.